Novel GvHD-Specific Gene Identification for Optimal Control of GvHD

ABSTRACT
Graft-versus-host disease (GvHD) is one of the most significant barriers to success for allogeneic hematopoietic
cell transplantation (allo-HCT). The goal of this project is to identify novel genes whose genetic/pharmacologic
blockade may selectively prevent GvHD while maintaining or enhancing anti-leukemia activities (aka graft-
versus-leukemia or GvL effect). Allo-HCT remains the most effective treatment for patients with hematologic
malignancies, as the therapeutic benefit of allo-HCT is primarily derived from GvL. However, allo-HCT also
carries the risk that the donor T cells in the transplant (graft) will become overzealous and begin to attack not
only the leukemia but also the patient's skin, intestines and liver, resulting in GvHD. Because of a strong
association between the two donor T cell-mediated immune responses, specifically limiting GvHD remains the
goal of allo-HCT. Managing the threat of GvHD would broaden the scope and benefit of allo-HCT. Several
groups, including ours, have proposed therapeutic strategies to reduce GvHD without abrogating the beneficial
GvL effect in animal models and human patients. However, the mechanisms by which allogeneic donor T cells
differentially modulate GvHD and GvL remain largely unknown. This gap in our mechanistic understanding
hinders our ability to specifically prevent/treat GvHD. We hypothesize that the genes we identify as being
differentially associated with donor T cells that infiltrate tumors versus GvHD organs will be critical targets for
the prevention of GvHD without negatively affecting GvL. To this end, we performed an unbiased genome-wide
CRISPR/Cas9 library screen. As a result, we have for the first time identified 487 novel GvHD-associated genes
that could potentially serve as molecular targets in GvHD, as the guide RNAs for these genes were enriched
only in T cells obtained from tumor nodules but not from any GvHD target organs. We found that five sets of
genes that are involved in known pathways are most significantly enriched in these 487 genes. All of these five
pathways are closely linked to the RELN-RAP1-FGFR3 axis that has not been actively investigated in the allo-
HCT field. Thus, we will determine if genetic/pharmacologic inhibition of the RELN-RAP1-FGFR3 axis results in
GvHD-specific immune modulation while maintaining or enhancing GvL in our mouse models of murine
GvHD/GvL and human PBMC/T cell-mediated xeno-GvHD/GvL. If successful, our findings of novel therapeutic
targets to selectively and optimally control GvHD will be potential game-changers. Our proposed studies will
provide significant mechanistic insights into GvHD and its prevention, which may have transformative
implications for therapeutic development not only for solid organ transplant rejection but also inflammatory
diseases such as inflammatory bowel disease, psoriasis and rheumatoid arthritis. In addition, our studies may
also help improve the efficacies of anti-cancer therapies and immunotherapeutic approaches
.

Public health relevance
Project Narrative: Allogeneic hematopoietic cell transplantation (allo-HCT) is the only curative therapy for many patients with hematologic malignancies and marrow failure states. Approximately 30-50% of patients receiving allo-HCT suffer from graft-vs-host disease (GvHD), the major complication of allo-HCT, due to human leukocyte antigen (HLA) mismatch. Our simple approach to overcome GvHD while preserving or enhancing the anti-leukemia effects of allo-HCT may provide an inexpensive, safe, and effective way of overcoming HLA barriers and permit the routine use of allo-HCT in patients who may not have suitable donors and improve outcomes.